Generation of Novel Genetic Tools to Study Cellular Heterogeneity in Adipose Tissues

Generation of Novel Genetic Tools to Study Cellular Heterogeneity in Adipose Tissues
Much attention has been dedicated over recent years towards developing a better understanding of the cell
types critically involved in maintaining energy homeostasis. In preclinical settings, the ability to direct the
expression of Cre recombinase to specific tissues has been a major advance. An additional advance was
made when these Cre-based recombination events were made inducible, with Cre activity temporally and
spatially controlled in adult animal models. The two investigators involved in this proposal (Gupta and
Scherer) have been at the forefront of the generation of mouse models now widely used in the metabolism
field, exploiting in each case the expertise in their respective cell types of interest in different adipose tissues.
The same two investigators now propose to take the adipose tissue- and cell type specific gene manipulation
to the next level. With single cell sequencing approaches becoming more commonplace and widely used, it is
increasingly obvious that a vast degree of cellular heterogeneity exists, even in cellular populations that were
long considered homogeneous. There is strong evidence that such heterogeneous gene expression patterns
reflect important functional differences, particularly in the areas of pre-adipocytes and adipocytes. We propose
the development of novel genetic tools to study cellular heterogeneity in adipose tissues. Using “Split-Cre”
methodology, we will coordinate efforts to direct enzymatic Cre activity to specific subsets of cellular
populations in different adipose tissues. This application builds upon existing gene expression databases
generated by the two investigators, and proposes to expand the efforts in finding additional unique or highly
enriched markers in the respective adipose depots and the cellular subpopulations. We will leverage our
collective expertise and institutional infrastructure to validate the efficacy and specificity of the proposed mouse
strains. These mouse models generated will constitute a new community resource and will benefit all adipose
tissue physiologists in the general field of energy metabolism. As an additional step to demonstrate proof-of-
concept and efficacy of these new models, we will use these newly generated mice to underline the
physiological relevance of selected subpopulations of cells. These mouse models generated under the
auspices of this application will constitute a new resource that will be made available to the community at large
in a manner similar to what we have done with our previously generated genetic tools, along with detailed
phenotypic data, expression data, and all other information of relevance, to allow for efficient and widespread
use of these new tool mice.

Public health relevance
Narrative We will generate novel genetically modified mouse models that can be used to target critical subpopulations of adipocytes and adipose tissue stromal cells containing pre-adipocytes; new genetic tools will be available to the entire research community and will greatly advance the research efforts to serve the core mission of the NIDDK.